Bridges to the Baccalaureate Research Training Program at Towson University

PROJECT SUMMARY/ABSTRACT
A diverse biomedical workforce is essential to ensure representation, creativity, and innovation in the field of
biomedical research and higher education. While minoritized students begin college as STEM majors at the
same rates as their well represented counterparts, they are less likely to graduate with a STEM degree. The
attrition of students from STEM majors is acutely seen in students who begin college at two-year institutions,
warranting increased support for transfer students. This training grant supports students as they transfer from
Baltimore City Community College (BCCC) and the Community College of Baltimore County (CCBC) to Towson
University and complete their bachelor’s degree in the biomedical sciences. This new training grant proposal
builds on the past success of our twenty years long R25 B2B and implements new strategies to empower and
support trainees as we transition to a T34 mechanism. Our program is designed to meet the following objectives:
1) Provide a dynamic and supportive training environment that promotes self-efficacy and science identity. We
aim for >85% of trainees to transfer to TU and for >90% of trainees who transfer to TU to graduate within
three years of transfer; 2) Cultivate a supportive and inclusive community that is integrated with active STEM
training programs at BCCC, CCBC and TU to provide professional development. All B2B trainees will
participate in professional development activities that expose trainees to biomedical career options and
promote career development skills; 3) Provide B2B trainees with the information and tools required to
successfully matriculate into post-graduate programs in the biomedical sciences. While the primary goal of the
B2B program is to support the transfer of and completion of bachelor’s degrees in biomedical fields, all B2B
trainees will receive mentoring that informs them of post-graduate opportunities in the biomedical field and
facilitates development of application materials for post-graduate study. We aim for at least 50% of trainees
to apply to post-graduate programs in the biomedical field within two years of completion of their
bachelor’s degree; and 4) Evaluate the effectiveness of B2B training components through annual program
evaluation and improved tracking of B2B alumni. We aim for tracking of >90% of B2B trainees for at least
fifteen years following admission into the B2B program.

Public health relevance
PROJECT NARRATIVE A diverse biomedical workforce with varied lived experiences is critical for facing complex challenges in biomedicine and public health. The proposed training grant will support minoritized students as they transition from Baltimore City Community College and the Community College of Baltimore County to Towson University where they will earn their bachelor’s degree while participating in research and professional development. This program aims to increase student retention and bachelor’s degree completion while facilitating their progression to advanced STEM education and careers in the biomedical workforce.